ORAL TORASEMIDE VS. FUROSEMIDE IN CHF PATIENTS

The purpose of this study is to evaluate the overall safety of oral Torasemide relative to Furosemide in once daily dosing in patients treated for symptoms of Congestive Heart Failure.